HIV-induced microbial alterations and inflammation in the lung of humanized mice

Abstract
Human immunodeficiency virus (HIV) is a major global health challenge. According to UNAIDS data 2020,
approximately 38 million people across the world are living with HIV. Antiretroviral therapy (ART) is not able to
clear the viral reservoir, leaving HIV-1 as an uncurable chronic disease. Despite viral suppression by ART, people
living with HIV (PLWH) have increased risks for developing chronic lung diseases, such as chronic obstructive
pulmonary disease, emphysema, asthma, primary lung cancer, and pulmonary arterial hypertension. Previous
studies have demonstrated that chronic lung inflammation predisposes PLWH to pulmonary complications.
Efforts to better understand the mechanisms underlying HIV-related lung diseases are needed. The lung
microbiome (i.e., a collection of all bacteria residing in the airway) plays a significant role in modulating lung
immunity and disease pathogenesis. Accumulating evidence has supported that PLWH on suppressive ART
harbor an altered lung microbiome compared to people without HIV infection. The enrichment of bacteria in the
genera of Prevotella spp., Veillonella spp., and Streptococcus spp. in the PLWH may contribute to chronic lung
inflammation. Human population-based lung microbiome studies have been mostly cross-sectional. They are
confounded by genetic and environmental factors and lack mechanistic insights. Longitudinal studies monitoring
the dynamics of lung inflammation and microbial alterations are needed to understand the crosstalk between
dysregulated immune pathways and lung microbial dysbiosis during HIV infection. Here we propose to use an
advanced humanized mouse model to better understand lung inflammation and microbial dysbiosis driven by
HIV infection. We have two specific aims to perform. Specific Aim 1 is to characterize the dynamics of lung
microbial alterations and immune perturbations at cellular and transcriptional levels in humanized mice from the
acute to chronic infection stages. We will also investigate how ART influence lung immunity and lung microbiome.
Specific Aim 2 is to examine the role of lung bacterial dysbiosis on the lung immune system and develop novel
approaches to reduce or resolve lung inflammation. We expect that our results will provide novel insights into
the crosstalk between pulmonary immune tone and the microbiome in the context of HIV infection and pave the
way for further mechanistic studies to better understand HIV-associated lung complications.

Public health relevance
Narrative HIV infection induces lung inflammation and bacterial dysbiosis, which leads to the increased risks of chronic lung diseases in people living with HIV (PLWH). Our knowledge about interplay between HIV-associated immune dysregulation and the lung microbiota is limited. This proposed study will use an advanced humanized mouse model to better understand HIV-driven lung inflammation and microbial changes and promote mechanical studies to develop better procedures for screening, preventing, and treating lung diseases in PLWH.